POSITRON EMISSION TOMOGRAPHIC IMAGING OF LUNG TRANSPLANT

Lung transplantation is the treatment of choice for end-stage lung disease, but survival after lung transplant remains disappointingly low. Acute rejection episodes put lung grafts at greater risk of failing. However, acute rejection is often clinically silent and difficult to detect by any means other than biopsy, which requires an invasive procedure. Therefore, noninvasive methods for detecting and quantifying the presence of acute rejection could potentially improve outcomes for lung transplant recipients by improving our ability to detect acute rejection that requires treatment. Because T cells must proliferate in the lungs to cause acute rejection, we propose using the novel positron emission tomography (PET) tracer [18F]ISO-1, which targets the proliferation marker sigma-2 receptor, also recently characterized as the progesterone receptor membrane component-1 (PGRMC1), to image T cell activation in lung grafts. We have shown that PET imaging with [18F]fluorodeoxyglucose ([18F]FDG) also detects acute rejection and can measure its response to treatment; therefore, we will evaluate the ability of [18F]ISO-1 and [18F]FDG to detect acute rejection in a novel mouse model of left lung transplantation and in human lung transplant recipients.

Public health relevance
This proposal develops new imaging techniques for detecting and quantifying acute lung transplant rejection. Lung transplantation is frequently the last option for end-stage lung disease, but survival remains poor. Investigators will be able to use these imaging techniques to better identify lung transplant recipients who need more intensive immunosuppression and determine whether their treatment is effective to reduce the risk of lung transplant failure.